Rapid Responses to Problem Drinking on College Campuses

DESCRIPTION (provided by applicant): The goal of the proposed research is to rapidly implement and evaluate a comprehensive intervention that will effect environmental changes in the community and campus environments to reduce the incidence of alcohol-related problems among college students in a school(s) chosen by NIAAA and matched with the Wake Forest University (WFU) Research Team. We will use an approach where members of the research team will work closely with NIAAA and the college to which we are matched. To achieve this goal, the proposed study has three specific aims: 1. Drawing on previous work by the investigators and others, assist NIAAA and the college design and refine a state-of-the-art intervention focused on changing both the campus and community environments to reduce alcohol use and alcohol problems among college students. 2. Provide technical assistance to support the implementation of this intervention with a high degree of intensity and fidelity. 3. Evaluate the impact of the evaluation using a quasi-experimental design with "objective" measures (e.g., alcohol-related injury rates, alcohol consumption violations, etc.) of alcohol use and alcohol related incidents and students' self-report and dormitory resident advisors' reports of alcohol use and alcohol-related incidents. In addition to a quasi-experimental design where two or more intervention schools are paired with control schools, three other designs are described to be considered by the steering committee. Although the environmental intervention should be more than one year, the minimum time would be one academic year with a one year follow up. A pilot study with a historically black college or university is also proposed.